Administrative Core

Modified Project Summary/Abstract Section

MONTANA INBRE ADMINISTRATIVE CORE SUMMARY
The role of the MT INBRE Administrative Core (AC) is to ensure that all institutions in the network and Cores work together to achieve the overall program goals. By building connections between institutions, cores, faculty, and students the AC will maximize the impact of our program. Efforts will be guided by continual and thoughtful monitoring of program activities with a goal of facilitating communication and building synergy. The AC is responsible for distributing and managing MT INBRE V resources and establishing and maintaining partnerships as well as program interactions with the External Advisory Committee (EAC), Steering Committee (SC), Executive Committee (EC), Project Leaders, and Cores. As the organizational nexus, the AC will schedule meetings, select key personnel, oversee research projects conducted within MT INBRE V, and conduct program evaluation. The paramount responsibility of the AC is to ensure that MT INBRE V remains focused on the goals of the program, which are to 1) expand the biomedical/health sciences research network and student pipeline in MT, and 2) improve the health of all Montanans through rigorous and ethical research. To realize these goals and accomplish MT INBRE V’s overall aims, the AC will achieve these Specific Aims: Specific Aim 1. Facilitate the MT INBRE V Leadership Team’s ability to build a strong and vibrant research base in the state. Specific Aim 2. Provide transformative career opportunities for students through research. Specific Aim 3. Support faculty recruitment and career development through funding, training, and networking. Specific Aim 4. Enhance programmatic impact using an evaluation, planning, and implementation cycle. Our overarching goal is to catalyze and strengthen the research culture at network institutions, encourage research excellence, and provide students with research opportunities that create a strong biomedical research workforce.